The role of dendrite-targeting interneurons in auditory cortex

DESCRIPTION (provided by applicant): The receptive fields of auditory cortical pyramidal neurons are produced by integrating multiple classes of excitatory inputs. These inputs carry different sorts of sound information and synapse onto different portions of pyramidal neuron dendrites. For example, excitatory intracortical inputs synapse more frequently onto the apical dendritic branch and tuft of pyramidal neurons and tend to carry more sound information about the edges of the spectral receptive fields. In contrast, thalamocortical inputs synapse more frequently near the soma of pyramidal neurons and tend to carry more sound information about the center of the spectral receptive fields. In addition to excitatory inputs, pyramidal neurons integrate inhibitory inputs from local cortical interneurons. These interneurons also display multiple classes that synapse onto different portions of pyramidal neuron dendrites. As one particular example, somatostatin-positive interneurons synapse predominantly onto the apical dendrites of pyramidal neurons. Because of the anatomical proximity between somatostatin-positive inhibitory synapses and excitatory intracortical synapses, I hypothesize that somatostatin-positive interneurons more strongly suppress or influence responses to intracortical inputs than thalamocortical inputs. The function of somatostatin-positive interneurons is important to understand because significant proportions of these interneurons tend to die in neurological conditions including aging, neuropsychiatric disorders, and hearing loss. To understand the changes in human neurological conditions, it is necessary to understand the functional consequences of such a loss of interneurons. In my previous work with mice that lose somatostatin-positive and other interneurons in early adulthood, I observed a compensatory weakening of intracortical inputs. I hypothesize that the loss of somatostatin-positive interneurons alone is sufficient to induce the compensatory weakening of excitatory intracortical inputs. To test these hypotheses about the interactions of somatostatin-positive interneurons and intracortical inputs in health and disease, I will conduct acute and chronic manipulations in vivo and in vitro. I will acutely activate somatostatin-positive interneurons usin optogenetics to observe their effect on intracortically-driven responses in vivo and in vitro. I wil also chronically ablate ~20% of somatostatin-positive interneurons using conditional Dlx1 mutants to examine the mice for compensatory weakening of intracortical inputs in vivo and in vitro. This work will connect the normal functional interaction of somatostatin-positive interneurons with intracortical inputs and the functional consequences for intracortical inputs from the loss of somatostatin- positive interneurons commonly observed in neurological conditions, including aging, hearing loss, and brain trauma.

Public health relevance
PUBLIC HEALTH RELEVANCE: To understand the conscious perception of hearing in normal and disease states, we must understand the interactions of the individual circuit elements in auditory cortex. The aim of this proposal is to characterize the functional role of somatostatin containing interneurons that are specifically lost in aging and other neurological conditions. This knowledge is necessary to understand cortical processing and therefore necessary to treat neurological diseases. __SpecificAimsTextDelimiter__ Specific Aims A pyramidal neuron in primary auditory cortex integrates multiple classes of inputs to produce its spectral receptive field. For example, primary thalamocortical inputs synapse near pyramidal neurons' somata1 and drive responses in the center of the receptive field2-4. In contrast, intracortical inputs synapse more heavily near pyramidal neurons' apical dendrites and tuft1, and drive responses at the edges of the receptive field2-4. Cortical inhibitory interneurons display a similar anatomical diversity5,6, but the functions of the different interneuron classes are currently debated7,8. Understanding the normal functions of cortical interneurons is important because various classes of interneurons are lost or altered in many neurological conditions including aging9-14, hearing loss15-19, traumatic brain injury20, and neuropsychiatric diseases12,13,21-25. The causal relationships between the loss of a particular class of interneurons and the specific deficits in any of these neurological conditions are largely unknown. Somatostatin-positive (SST+) interneurons are particularly interesting for three reasons. First, these interneurons are preferentially lost in several neurological conditions including aging10-14, Alzheimer's disease12,13,24,25 and traumatic brain injury20. Second, SST+ interneurons target the apical dendritic regions of pyramidal neurons26-31, where excitatory intracortical inputs arrive1, suggesting they may have a strong effect on intracortical processing. Third, the loss of these interneurons may be linked with the apparent weakening of intracortical inputs I observed in my previous work with Dlx1 knockout mice32. These mice lose 20% of SST+ and vasoactive intestinal peptide-positive interneurons in early adulthood32. We observed that in the primary auditory cortex of these mice, spectral receptive fields were narrower and lacked the normal long-latency, edge responses32. Because acute, pharmacological blockades of inhibition broaden, rather than narrow, spectral receptive fields33-37, and long-latency edge responses are dominated by intracortical connections2-4, the narrower receptive fields are likely the result of compensatory changes in intracortical excitatory networks. Therefore, I hypothesize that the normal functional role of SST+ interneurons is to regulate responses to intracortical inputs, and that the chronic loss of SST+ interneurons in Dlx1 knockout mice will evoke compensatory changes in intracortical excitatory connections. The objective of this proposal is to determine the normal, acute functional role of somatostatin-positive (SST+) interneurons in A1, and how this relates to the chronic functional consequences following the specific loss of these interneurons. Aim 1 is to demonstrate that SST+ interneurons selectively suppress responses to intracortical inputs. I will use transgenic mice to express channelrhodopsin in somatostatin-positive interneurons. This will allow me to activate these interneurons using blue light, and compare their suppression of intracortically and thalamocortically driven responses in two ways: Aim 1.1 is to demonstrate that SST neurons preferentially suppress responses at the edges, rather than the center, of neurons' receptive fields. I hypothesize that activation of somatostatin-positive interneurons will more strongly suppress receptive field edges, which are primarily driven by intracortical connections2-4. This sub-aim will demonstrate the effects of SST+ interneuron activity on in vivo auditory processing. Aim 1.2 is to show that SST+ interneurons selectively suppress responses to electrical stimulation of intracortical versus thalamocortical pathways in vitro. I hypothesize that activation of SST+ interneurons will more strongly suppress responses to intracortical stimulation. This sub-aim will demonstrate that SST+ interneuron activity has specificity towards suppressing intracortical inputs. Aim 2 is to demonstrate that a chronic loss of SST+ interneurons induces compensatory changes in the strength of excitatory intracortical connections. I will conditionally knock out Dlx1 in only SST+ interneurons. This manipulation selectively eliminates 20% SST+ interneurons in early adulthood. I will then use two techniques to examine resulting functional and synaptic compensation: Aim 2.1 is to show that, following the loss of SST+ interneurons, responses at the spectral receptive field edges are abnormal. I hypothesize that following loss of SST+ interneurons, these edge responses will be reduced, consistent with compensatory changes in intracortical excitation. This sub-aim will demonstrate the functional changes in auditory processing following long-term loss of SST+ interneurons. Aim 2.2 is to show that the amplitude and/or frequency of miniature excitatory post-synaptic currents onto pyramidal neurons are abnormal after the loss of SST+ interneurons. I hypothesize that the amplitude and/or frequency of these miniature post-synaptic currents will be reduced in the conditional knockout mice. This sub-aim will demonstrate that excitatory connections are altered following the long-term loss of SST+ interneurons, and lay groundwork for further studies to determine whether these changes are specific to intracortical connections.